Administration

Shared Resource Core C. Administration. Darell D. Bigner, M.D., Ph.D., Core Director Support is requested for an Administrative Core including effort for Dr. Darell Bigner as P01 Program Director and Principal Investigator and Director of the Administrative Core. Dr. Bigner will provide oversight of the scientific and administrative activities of the program project grant. Dr. Bigner will chair the P01 Executive Committee which includes all research project leaders and shared resource core directors (Drs. Michael Zaiutsky, John Sampson, James Vredenburgh, and Daniel Barboriak). Together they will foster communication and collaboration between the research projects and shared resource cores and monitor and assess progress. Dr. Bigner will meet weekly with research project leaders and shared resource core directors, and he and his staff will serve as the editorial review/clearinghouse for all publications resulting from P01 activities. Dr. Bigner will plan and coordinate regular seminars which will include the P01 project leaders, core directors and investigators. These seminars will be a part of the monthly Neuro-Oncology Program Seminar Series coordinated by Dr. Bigner. Dr. Bigner will coordinate the participation of P01 investigators in national and international workshops, conferences, and meetings on brain tumor research. Also he will coordinate all the activities of the P01Internal and External Advisory Committees and will serve as the P01 liaison with other appropriate academic units within Duke University and with outside entities. Core support is requested for a Staff Specialist who will be responsible for scheduling all internal and external meetings, budgetary monitoring, and general administrative assistance. Core C will provide administrative support for all three research projects and the two shared resource cores.

Public health relevance
The Administrative Core is necessary to coordinate all the scientific and administrative activities in the program project grant, all of which are designed to develop new, innovative, more effective, and less toxic treatments for CNS tumors.